Dynamics of Cellular Brain Metabolism Using Mass Spectrometry Imaging

PROJECT SUMMARY/ABSTRACT
Brain function demands a lot of metabolic energy, often in brief, local bursts. The ability of each brain cell’s
metabolic machinery to respond to this energy demand is crucial both for the immediate functional properties of
brain signaling and for the long-term health of the brain. Although the core metabolic pathways are shared by
all types of brain cells, we hypothesize that different brain cell types are likely to emphasize different metabolic
components in response to acute energy demand. For instance, neurons and astrocytes are thought to play
complementary metabolic roles; and neurons that fire nearly constantly, or episodically at very high rates, may
manage their metabolism differently from typically quiescent neurons. Dysfunction in metabolism can lead to
disease and neurodegeneration, and the metabolic differences between cell types may underlie the very cell-
type-specific vulnerabilities of brain cells seen in neurodegenerative diseases.
To study the distinctive, dynamic metabolic responses of specific cell types in intact tissue, rather than cell
culture, we will perform physiological experiments on acute brain slices from mice, using neuronal stimulation,
13C metabolic labeling, and metabolic inhibitors. We will then use mass spectrometry imaging (MSI) to
quantitatively map the levels of numerous metabolites in thin sections from those brain slices. Fast thermal
preservation (flash heating and freezing) of the brain slices at specific times after stimulation or application of
13C-labeled metabolites allows us to measure a fine time course of metabolic changes, and the imaging capability
allows us to obtain metabolic measurements from specific cell types. Dentate granule cell (DGC) metabolic
behavior will be isolated by MSI of the compact granule cell layer of the hippocampus; the metabolic signals from
single astrocytes and fast-spiking parvalbumin-positive interneurons will be isolated using cell-type specific
signatures, based on correspondence with labeling by established antibodies.
We will use these methods to construct a rich picture of how these individual cell types use their core metabolic
pathways (glycolysis, pentose phosphate pathway, TCA cycle), both at baseline and dynamically in response to
neuronal stimulation. We will test the specific hypotheses that in DGCs, neuronal glycolysis is upregulated after
stimulation, and that the pentose phosphate pathway then becomes engaged. Experiments using fuel molecules
with different stable isotope labels will reveal how neurons and astrocytes flexibly utilize a mixture of energy
sources. By combining data on metabolite levels with data on the activity of individual metabolic pathways, we
can learn not only what the metabolic changes are, but also the positions along each pathway at which key
regulatory changes occur. And we will test the hypothesis that DGCs, astrocytes, and fast-spiking interneurons
use their core metabolic pathways distinctively in response to neuronal stimulation.
This project will reveal the distinctive metabolism of different cell types in healthy brain tissue and lay a foundation
for future work on how metabolism may go awry (as is suspected) in aging or in neurodegenerative disease.

Public health relevance
PROJECT NARRATIVE (Public health relevance) Proper brain function requires a lot of energy from fuel molecules like glucose, and this energy supply process is highly regulated at the level of individual brain cells and from moment to moment. We know surprisingly little about how this regulation works, and how it goes awry (as it is thought to do) in aging or in neurodegenerative disease. This project will discover the key details of brain cell energy metabolism, including its dynamic response to brain activity and how it varies among different cell types in the brain, and this knowledge will enable future work on disease mechanisms and how they might be corrected by therapeutics.